Associate-Director Flow and Image Cytometry Roswell Park ComprehensiveCancer Center

The current application seeks continued salary support for Hans Minderman, PhD who serves
as the Associate Director of the Flow and Image Cytometry Shared Resource (FICSR) of the
Roswell Park Comprehensive Cancer Center (Roswell Park). This position was created in 2007
to oversee the research applications of the various imaging (confocal, live cell imaging) and flow
cytometry platforms available in the facility and to apply his extensive experience in these areas
in collaborations and consultations with the FICSR investigator user base. With over 35 years of
experience in clinical and research applications of flow and image cytometry (30 years at Roswell
Park), Dr Minderman throughout his career has collaborated with many investigators at the
Cancer Center on NIH funded projects. The FICSR is an integral part of Roswell Park’s Cancer
Center Support grant (P30CA016056) for which the cancer center Director, Dr Johnson serves
as the Principal Investigator. The Tumor Immunology & Immunotherapy (TII) CCSG program,
previously co-led by the Unit Director on the original application, Dr Odunsi, is the major user
base of the FICSR; but numerous NIH-funded researchers across all 5 CCSG programs actively
collaborate and consult with Dr Minderman commensurate with the purpose of the PAR 21-286
funding opportunity. During his first R50 tenure (2016-2021), Dr Minderman’s contributions to
Roswell Parks research enterprise have been significant and impactful specifically with regards
to the NIH-funded research. As of October 2021, 137 extramural grant applications dependent
on FICSR were awarded to Roswell Park faculty, 59 were awarded by NIH, 22 of which to
members of the TII program. The cancer center has also made significant investments in the
FICSR with the acquisition of a new confocal microscope, two spectral flow cytometry analyzers
and a 3rd Fortessa analyzer. With the changes in the R50 program now making the distinction
between Laboratory (PAR-20-288)- and Core (PAR-20-287)-based scientists and with the FICSR
being an integral part of the Roswell Park CCSG infrastructure, Dr Johnson as the PI of the
CCSG grant, will now serve as the Unit Director for the renewal application.

Public health relevance
Project Narrative: The Flow and Image Cytometry Shared Resource is an integral part of the Roswell Park Comprehensive Cancer Center (Roswell Park) Cancer Center Support Grant (CCSG) program (P30CA016056, PI Johnson). As the Associate Director of the Flow and Image Cytometry Shared Resource with over 35 years of relevant experience, Dr Minderman’s efforts are solely dedicated to supporting all 5 CCSG research programs with regards to developing, validating and optimizing flow and image cytometry-based assays, consultation on experimental design, data analysis, interpretation, reporting, education and oversight of maintenance/QC of the equipment in the Resource. His insightful intellectual and practical contributions on how cutting edge flow and image cytometry applications can aid the many NCI-funded projects at the cancer center and that of the CCSG program members in particular are invaluable. Continued funding of Dr Minderman as NCI Core-based Research Specialist will ensure the stability of an essential resource to Roswell Park’s CCSG program.